PolQ as a novel therapeutic target in AML

Acute myeloid leukemia (AML) is the most common type of acute leukemia among adults with overall
poor prognosis. More specific therapies have been developed against FLT3(ITD/TKD)-positive AML
(FLT3 tyrosine kinase inhibitors, TKi). Still, complete remissions are rare, and after initial
response the leukemia invariably progresses within a few months.
AML cells accumulate lethal DNA double-strand breaks (DSBs), but DSB repair pathways
maintain their survival. BRCA1/2-mediated homologous recombination (HR) usually plays a major role
in DSB repair. However, we reported that leukemias expressing AML1-ETO and PML-RAR, 15- 35% of
karyotypic normal AMLs, and TKi – treated FLT3(ITD/TKD)-positive AMLs (39% of karyotypic
normal AMLs) are HR-deficient. Proliferation of HR-deficient solid tumor cells depends on DNA
polymerase theta (Polθ) encoded by POLQ gene, which promotes a backup DSB repair called
microhomology-mediated end-joining (MMEJ). According to cBioPortal database AMLs express the
highest levels of POLQ mRNA among all tumors. Western blot analysis detected high levels of Polθ in
AML cells when compared to normal counterparts. Altogether, these findings
supported by preliminary data suggest that survival of AML cells (especially
HR-deficient), which are under constant genotoxic stress, depends on Polθ. Therefore,
Polθ may be a novel and promising drug target in AML.
Our preliminary data suggest that AML-inducing mutations [FLT3(ITD/TKD) +/- TET2mut,
DNMT3Amut, MLL-AF9, AML1-ETO] can modulate the sensitivity of AML cells to the inhibition of Polθ.
Therefore, in Aim #1 we will inhibit Polθ (shRNA, mutants and Polq-/- cells) and introduce
AML-inducing mutations (retroviral infection, CRISPR/Cas9) to pinpoint mutations,
which predispose leukemia cells to be sensitive to Polθ inhibition +/- standard cytotoxic drugs.
Using high throughput screening followed by biochemical testing and in vitro cellular sensitivity
assays, we identified Polθ inhibitors (Polθi) that specifically kill HR-deficient primary AML
cells. In Aim #2 we will further develop Polθi towards novel drug-like entities as targeted
therapeutics for AMLs.
In Aim #3 we will employ murine AML-like models, primary AML cells and xenografts to test
therapeutic potential of inhibition of Polθ combined with (1) other DNA repair inhibitors (RAD52i,
PARPi) against HR-deficient AMLs, and (2) standard cytotoxic drugs against HR-proficient AMLs.
We anticipate that Polθi developed in these studies will be effective against a wide-range of AMLs
and ultimately will be advanced to clinical trials.

Public health relevance
Although tremendous progress has been made in treatment modalities of acute myeloid leukemia (AML), there is the necessity to improve and develop novel therapeutic approaches. Recently, we have identified that DNA polymerase theta (Polθ) is a key player in a novel DNA repair pathway that is essential for the proliferation of leukemia cells, but expendable in normal cells. Selective inhibitors of Polθ have been identified in our laboratories. We aim to develop a drug-like Polθ inhibitor that will selectively kill AML cells, while sparing healthy cells.